Protein-RNA interactions in cancer

PROJECT SUMMARY/ ABSTRACT
Protein-RNA interactions underlie an important and understudied component of gene regulation. RNA-binding
proteins carry out numerous functions relating to the production, splicing, processing, and stability of mRNA
molecules. A few years ago, we discovered that the oncofetal RNA binding protein, IGF2BP3, binds to the 3’
untranslated region of mRNA and regulates mRNA stability via a mechanism that involves the RNA-induced
silencing complex. In more recent work, we found that IGF2BP3 also binds near 3’-splice sites, and may
regulate alternative splicing. Together, our findings suggest dual roles in mRNA regulation for IGF2BP3.
IGF2BP3 regulates genes that are related to proliferation, migration, and signaling- which are important in fetal
development- but also in cancer. Concordant with this gene regulatory function, IGF2BP3 is overexpressed in a
wide range of malignancies, including acute leukemia, and portends a poor prognosis when highly expressed.
Using novel, murine genetic models of IGF2BP3 deficiency, we have now discovered that IGF2BP3 is required
for the development of a fully-penetrant, lethal leukemia in vivo. Together, our extensive prior work, both
published and unpublished, provides a mechanistic framework for its function, and a solid foundation for the
importance of this protein in disease. To fully understand the nature of these protein-RNA interactions and to
understand their role in cancer, we propose two aims. In the first aim, we will carefully delineate the mechanism
underlying IGF2BP3 function by a combination of carefully executed experiments (Aim 1). In the second aim,
we will characterize the importance of IGF2BP3 in leukemia initiation, propagation and maintenance using a set
of carefully constructed genetic models and gene editing in primary cells. Next, we will characterize how the two
proposed gene regulatory mechanisms- RNA stability and pre-mRNA splicing- play roles in cancer initiation,
using a combination of reverse genetics, miRNA regulation, and isoform specific expression. Together, this work
will lead to a layered, detailed understanding of how mechanistic basis of protein-RNA interactions is intimately
connected to gene expression deregulation and the malignant transformation of cells. Importantly, it will pave
the way to develop novel diagnostic and therapeutic approaches in malignancies characterized by massive
transcriptomic dysregulation underpinned by alterations of RNA-binding proteins.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Despite decades of research and much progress, certain subtypes of leukemia remain highly resistant to treatment. Our recent work shows that one determinant of the aggressive behavior of leukemia is a protein that regulates post-transcriptional gene expression, insulin-like growth factor 2 mRNA binding protein 3 (IGF2BP3). By determining how this protein contributes to leukemia causation and understanding the underlying mechanism, we will define novel diagnostic, prognostic and therapeutic approaches in these highly aggressive malignancies.